SenNet Supplement - Consortium Benchmarking

Project Abstract
The purpose of the Supplement is to further the CODCC Administrative Core (Sub-Section C:
Administrative Core: Including Consortium Coordination & Outreach) in two areas: 1. comparing
the performance of spatial transcriptomics and proteomics techniques on the same tissue, and
2. comparing the performance of the same modality on different tissues. The SenNet
consortium is working together to develop and apply multiple spatial imaging technologies to
investigate the molecular and cellular heterogeneity of cellular senescence in aged tissues.
However, one major obstacle faced by the consortium is the uncertainty surrounding the ability
of the various technologies being employed to robustly characterize senescent cells in different
tissues. To address this challenge, the SenNet consortium will undertake a collaborative effort
to test the effectiveness of various spatial omics technologies on the same human tissue across
different sites, as well as to test their effectiveness across different tissues. This endeavor aims
to accomplish several goals: firstly, to determine the robustness of senescence-associated
marker detection based on the platform, secondly, to extract diverse information about
senescence from the same tissue. This consortium-wide benchmarking project will focus on
spatial omics techniques that offer single-cell resolution. This approach is based on the current
understanding that senescent cells are present in relatively low abundance in aged tissues and
the need to use technologies that can accurately detect individual senescent cells and
differentiate them from surrounding cells. By rigorously testing the robustness of high-plex
technologies already in use within the SenNet Consortium across multiple sites and tissues, we
will determine which techniques are most accurate and informative in detecting senescent cells
in different tissues.

Public health relevance
Project Narrative The purpose of the Supplement is to further the Cellular Senescence Network (SenNet) in two ways, furthering the goal of enabling standardization of detecting cellular senescence and spatial localization of senescence in tissues: 1. comparing the performance of spatial transcriptomics and proteomics techniques on the same tissue, and 2. comparing the performance of the same modality on different tissues.